BRAIN CONNECTS: Light microscopy for cell-type specific mesoscale to nanoscale dense connectomics

PROJECT SUMMARY
In recent years, there has been remarkable progress in mapping the connectivity of cell types in the brain. We
now have complete connectomes for insects and worms, and in mammals, we can map synapse connectivity
across millimeter-scale regions. As the BRAIN CONNECTS program aims to extend this capability to entire
mammalian brains across multiple scales, it is essential to link these connectivity breakthroughs with the brain's
molecular architecture. Until now, the connection between fine connectivity obtained through electron
microscopy (EM) and molecular cell types has been established through indirect methods such as Patch-seq.
Recent developments in light-microscopy-based connectomics (LICONN) have shown promising results for
dense connectivity mapping. LICONN has the potential to register connectomics results to molecular subclasses
at the single-neuron level and at scale. This project leverages LICONN and our expertise in creating and
analyzing EM data to address three main objectives of the BRAIN CONNECTS program.The first objective is to
demonstrate that LICONN can be used to create molecularly informed cell type connectivity patterns by
integrating its results with large-scale EM data. This approach can provide a powerful tool to establish a ground
truth link between molecular and connectivity types across datasets planned with the CONNECTS portfolio. The
second objective is to combine light-microscopy-based connectomics with Mesoscale Expansion Microscopy in
a multiscale fashion. This integration allows mapping microscale connectivity in gray matter and linking it with
white matter connections between brain regions. The third objective is to test the feasibility of expanding LICONN
to larger volumes and scale nanoscale expansion microscopy. The goal is to demonstrate that regions larger
than a cubic millimeter can be expanded 16 times to achieve LICONN resolution, which is about ten times greater
than the current state-of-the-art.

Public health relevance
PROJECT NARRATIVE Understanding the structure of our brains is crucial for seeing how brain functions arise from the complex network of neural connections and how these connections break down in diseases. This research aims to develop technologies that link the connections between neurons to specific types of brain cells and scale up the mapping of these connections to the entire human brain. These advancements can significantly enhance our understanding of how different brain cell types contribute to brain function.